U-RISE at the University of Puerto Rico at Humacao

PROJECT ABSTRACT
The main long-term goal of the UPRH U-RISE Program is to increase the pool of talented minority
undergraduates with the required academic preparation and research experience to be competitive to win
admission to top graduate programs, and complete a Ph.D., M.D./Ph.D., or equivalent degree, in disciplines
relevant to biomedical research. We propose the following measurable objectives for the upcoming five-year
U-RISE grant period: a) 100% of our students will finish their B.S.; b) at least seventy percent (70%) of the
participating undergraduates in our U-RISE Program will enroll in graduate programs leading to a Ph.D. in the
biomedical sciences within three years of graduation; c) a publication rate of at least one research paper per
year in peer-review journals throughout the entire funding period of the proposal will be maintained, where one
of the authors is a U-RISE UPRH student. Based on the experience of having the MARC Program at UPRH
for 34 years, suggestions from previous Advisory Committees, feedback provided by former MARC students,
and an intensive evaluation scheme, our program will be designed to provide the student with the following
competencies, which we believe are crucial for a successful transition to a graduate program: intensive
research training, critical thinking development, communication skills, training in quantitative/computational
analysis, and preparation for entrance to graduate school. To accomplish this, our program proposes activities
organized in the following Program Components: the U-RISE Curriculum, Research Opportunities, Academic
and Career Advisement, Seminar and Guest Speaker Program, Workshops and other Developmental
Activities, Peer-mentorship among Trainees, and Community Outreach. The UPRH U-RISE Program
proposes to train twenty (12) undergraduate students per year for biomedical research careers. Our trainees
will participate in our program for two (2) years, beginning at the end of their sophomore year. Participants will
be tracked throughout their undergraduate work through an intensive evaluation plan. This plan will provide
feedback for constant upgrading of the program. After completing the UPRH U-RISE Program, our trainees
will have the required academic preparation and research experience to do graduate work in fields such as
Biochemistry, Biophysics, Microbiology, Cell Biology, Neuroscience, Cancer Biology, Organic Chemistry,
Developmental Biology, and other biomedical research areas.

Public health relevance
PROJECT NARRATIVE The Undergraduate Research Training Initiative for Student Enhancement (U-RISE) Program of the University of Puerto Rico at Humacao will increase the number of underrepresented minority students that will pursue graduate studies in the Biomedical Sciences. This will contribute to diversify the nation’s biomedical research workforce. We will accomplish our goal by providing our students with intensive research training, critical thinking development, communication skills development, interpersonal skills development, and preparation for entrance to graduate school.